Administrative Core

The Administration Core will provide administrative resources to the PI, the project leaders and the core directors to ensure the success of the PPG. The core will have three specific aims. Aim 1 will provide administrative support, including secretarial and financial management support for the PPG. Aim 2 will foster synergy and communication among projects and cores through regularly scheduled meetings. Aim 3 will manage interactions between the PPG investigators, advisory boards and the NHLBI. The Core Director will facilitate the mission of the overall program project, and has responsibility for all program components and their activities. All project investigators will utilize the Administrative Core as it is essential for the administrative oversight of the projects. The Administrative Core will be integral in planning and evaluation, communication within the program team and with outside institutions, providing scientific and administrative leadership, and overseeing operations of the Human Subjects Core and the Biospecimen and Bioinformatics Core. Additionally, the Administrative Core will plan meetings of the scientific and evaluation committees. Secretarial support will be provided through this core for internal and external program report preparation, manuscript proofreading and correspondence.

Public health relevance
RELEVANCE (See instructions): Core A will provide a resource for high quality administrative support and leadership for this PPG.